The role of oxidative stress in reduced microvascular function after gestational diabetes

PROJECT SUMMARY/ABSTRACT
Women with a history of gestational diabetes mellitus (GDM) are at a ~2-fold greater risk for cardiovascular
disease (CVD) and a ~7-fold greater risk for type II diabetes mellitus (T2DM) in the decade following
pregnancy, but the underlying cause(s) of this association are relatively unstudied, and there is a paucity of
trials evaluating preventive intervention to prevent or delay this onset of disease. Microvascular dysfunction
precedes and contributes to the development of CVD and insulin resistance in humans, via reductions in
endothelial-derived nitric oxide (NO) and insulin-mediated NO-dependent vascular responses, respectively. We
have demonstrated that endothelium- and nitric oxide-dependent dilation are attenuated in the
microvasculature of otherwise healthy women with a history of GDM and this reduction is mediated, in part, by
increased oxidative stress. However, the degree to which this attenuation in dilation extends to microvascular
insulin-mediated responses is unknown. Therefore, in aim 1, we propose a comprehensive examination of the
role of oxidative stress in attenuated microvascular endothelial insulin sensitivity in otherwise healthy women
who have had GDM. Our preliminary data suggest that nicotinamide adenine dinucleotide phosphate oxidase
(NADPH oxidase) contributes significantly to elevated reactive oxygen species after GDM, and that inhibiting
NADPH oxidase improves endothelial- and NO-dependent dilation, in vivo in these women. Therefore, in aim
2, we propose a comprehensive examination of the role of NADPH oxidase-derived reactive oxygen species --
which represent a future pharmacological target for the highly specific treatment and reversal of preclinical
vascular dysfunction after GDM -- in attenuated microvascular endothelial function in these women. Metformin
treatment improves vascular endothelial function and microvascular insulin sensitivity in patients at risk for
T2DM, in part through reductions in oxidative stress, suggesting that metformin treatment applied before the
onset of insulin resistance may improve microvascular endothelial responses in women with a history of GDM.
Therefore, in aim 3, we propose to examine the acute and chronic effects of metformin treatment on oxidative
stress-mediated mechanisms of microvascular dysfunction in otherwise healthy women with a history of GDM.
Overall, using an innovative translational human approach that combines in vivo pharmaco-dissection of
mechanisms of vascular function with the biochemical analysis of biopsied endothelial cells, the experiments
proposed herein will provide novel understanding of 1) early vascular mechanisms preceding the development
of overt cardiovascular and metabolic disease in women who have had GDM , and 2) mechanistically delineate
the efficacy of a readily available, safe, and inexpensive treatment to restore microvascular function before the
onset of disease in this high-risk cohort of women.

Public health relevance
PROJECT NARRATIVE Women who develop gestational diabetes during pregnancy are two times more likely to develop cardiovascular disease and 7 times more likely to develop type 2 diabetes in the decade after pregnancy, but the reason why this occurs is unclear and there are currently no specific treatment strategies to prevent this disease progression. This project addresses this public health issue in three ways: examining if woman with a history of gestational diabetes have reduced micro-vessel responses to insulin (aim 1), delineating if oxidative stress is the cause of this reduced function and where this oxidative stress is coming from (aim 2), and examining if metformin treatment after pregnancy is able to specifically reverse this micro-vessel dysfunction (aim 3). Answering these questions will increase our understanding of what causes elevated disease risk after gestational diabetes and lay the foundation for trials of mechanism-specific treatment and prevention strategies in these women with high lifetime cardiovascular and metabolic disease risk.